SALSA - Study of Active Lifestyle Activation

PROJECT SUMMARY / ABSTRACT
Children and adolescents diagnosed with cancer now have, on average, nearly 85% 5-year survival. However,
premature cardiovascular (CV) disease has become the leading non-cancer cause of late mortality among
childhood cancer survivors. There is a robust body of evidence from the general population, and increasingly,
among cancer survivors (even those exposed to cardiotoxic cancer therapies), that greater physical activity (PA)
and improved diet quality can reduce future CV-related morbidity. However, while many general population and
cancer-specific intervention studies have focused on a single lifestyle factor (e.g., PA or diet alone), given the
interplay between PA and dietary factors in influencing CV health, a multi-faceted approach may result in overall
better long-term CV health profiles. Research on lifestyle interventions in cancer survivors also has been
predominantly conducted in women with breast cancer, and the evidence for survivors of childhood cancer is
limited. To accomplish our aims, we will use the largest prospectively followed childhood cancer survivor cohort
in the world, the Childhood Cancer Survivor Study (CCSS; n>24,000), to recruit adult-aged participants at
increased risk of early CV disease (n=403) for a remotely conducted 12-month randomized controlled trial testing
a multi-faceted approach at improving PA and diet quality. Specifically, the study will use a sequential multiple
assignment randomized trial (SMART) design, where participants with low PA or poor diet will first be randomized
between intervention and control conditions. Intervention participants will be further randomized to receive either
clinician-led telehealth sessions focused on risk factor self-management, or weekly mobile health (mHealth)
supported individualized PA and dietary goal-setting with social media peer support. The adaptive SMART
design will allow further tailoring of the intervention experience based on initial response, which may increase
overall intervention efficacy. Participants not initially responsive to their assigned intervention will be further
randomized to receive an alternate intervention. The study will use consumer-grade mHealth applications that
track PA and diet, thereby increasing future dissemination capacity. The study’s primary analyses will determine
the overall intervention efficacy and whether specific intervention strategies and sequence of strategies are
associated with optimal outcomes. Secondary analyses will examine potential predictors, mediators, and
moderating factors associated with PA and dietary changes over time, as well as changes in participants’
cardiometabolic profiles. In summary, lifestyle change represents one of the few available strategies to mitigate
CV risk in childhood cancer survivors. Significant barriers (e.g., time, training, resources) limit the ability of
healthcare systems to facilitate such change. To fill this void, remote-based, personalized, and easily
disseminated multi-faceted mHealth-supported interventions may play a transformative role.

Public health relevance
PROJECT NARRATIVE With improved treatments, the vast majority of children diagnosed with cancer are now cured. However, premature cardiovascular disease has become the leading non-cancer cause of death among childhood cancer survivors. Using an adaptive study design, the proposed trial seeks to determine if various innovative intervention strategies can help childhood cancer survivors improve their physical activity and dietary habits in order to reduce their long-term risk of early cardiovascular disease.